Transcriptional basis of stereotyped neural architectures

ABSTRACT
Recent advances in high-resolution volumetric imaging and single-cell RNA sequencing have enabled the
characterization of neuronal diversity and the genetic programs that specify identity. Meanwhile, our
understanding of the diversity of synapses and their genetic underpinnings remains limited. Decoding the genetic
programs responsible for the formation and maintenance of neural architectures can help us understand the
functional role of synapses in the brain and offer entry points towards designing genetic targets for the treatment
of mental health disorders related to brain connectivity.
Based on the evidence of conservation of neural architectures in a wide range of neural systems and strong
preliminary results in C. elegans, I hypothesize that synaptic connectivity is genetically encoded. Specifically, I
hypothesize that complimentary gene combinations specify pre-synaptic neurons and their post-synaptic neural
partners (resembling a "key-and-lock" combination). Single-cell RNA sequencing and single-cell resolution
connectivity datasets make this hypothesis testable. I will test this hypothesis in two parallel aims using the
computational Network Differential Gene Expression (nDGE) tool I have pioneered. This technique integrates
single-cell resolution gene expression data with single-cell resolution connectivity to assign statistical
significance to combinatorial genetic patterns enriched in synaptically connected neurons. Across two aims, I
will investigate the transcriptional encoding of the structural and functional connectome of C. elegans (Aim 1)
and the micro-connectivity of pyramidal cells and interneurons in the CA1 region of the rodent hippocampus (Aim
2). To accomplish these aims, I will build additional computational tools to extract a functional connectome in C.
elegans (Aim 1b) and harmonize spatial transcriptomic data with functional calcium imaging data in the rodent
hippocampus (Aim 2a). Together, these aims will provide two substantial entry points towards elucidating the
genetic programming of neural architectures across multiple animal nervous systems. Additionally, these aims
will generate valuable computational tools for the benefit of the molecular and systems neuroscience community
as a whole. The multiple animal approach will ensure the robustness and biological validity of the computational
models and tools that I will introduce to the neuroscience community.
During the K99 phase of this award, occurring within Columbia's vibrant neuroscience community, I will be
mentored by Dr. Liam Paninski, Dr. Oliver Hobert, and Dr. Attila Losonczy while consulting with Dr. Larry Abbott,
and Dr. Ashok Litwin-Kumar. These professors represent diverse expertise in computational, molecular, and
systems-level neuroscience in C. elegans and rodent models. They will guide me to hone my computational
skills further and provide needed training in molecular and circuit neurobiology during my transition to becoming
an independent computational investigator at the interface of molecular and systems neuroscience.

Public health relevance
NARRATIVE Many complex disorders of the brain, such as schizophrenia, autism, and depression, can be construed as disorders of brain connectivity. This research aims to bridge the gap between gene expression and connectivity towards elucidating the genetic programming of neural circuit architectures. Decoding the genes that play a role in the formation and maintenance of neuronal networks can provide entry points toward developing therapeutic targets for mental health disorders related to brain connectivity.